Suppression of forkhead box M1 (FoxM1) transcriptional activity via inhibition of DNA binding

Project highlights: primary screening has been completed and follow-up studies have confirmed a putative inhibitor of FoxM1-DNA binding. Analogues of this compound, as well as several additional chemotypes, are currently being validated. Further development of a selected compound series will be initiated once extended characterization of hits is complete. During this period, the NCGC has fostered and maintained over 180 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to over 100 high-throughput screens and nearly 60 medicinal chemistry campaigns, providing our collaborators and the general research community a wealth of publications and promising small molecule leads. In addition, the NCGC has undertaken a number of informatic challenges to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.